Using Ecological Momentary Assessment To Characterize Dynamic Patterns of E-Cigarette Use in Adults Planning to Quit Vaping

PROJECT SUMMARY/ABSTRACT Approximately 10.8 million adults in the United States report regular e-cigarette use (“vaping”). While e-cigarette use may have some potential as a smoking cessation aid, it may lead to continued, unwanted long-term use. Despite the fact that the majority of e-cigarette users plan to quit vaping there are no empirically supported treatment resources specifically designed to address e-cigarette use and we lack crucial information needed to develop targeted interventions. We will examine (1) how e-cigarette use ? and attempts to quit ? unfold in real time, (2) which factors precede quit attempts (e.g., intent to quit, cravings, e-liquid flavor), and (3) over what time period these factors are relevant. The current study will use ecological momentary assessment (EMA) with 100 exclusive daily e-cigarette users who report plans to quit vaping in the next 30 days to characterize dynamic patterns of e-cigarette use and quit attempts during that 30-day period. Eligible participants include those between the ages of 21 and 60 who report current (past 6 months) daily e- cigarette use, interest in quitting e-cigarettes within the next 30 days, live in the United States, have a smart phone, and who deny use of cigarettes or daily use of an FDA approved cessation aid to help quit e-cigarettes in the past 30 days. The proposed study has two specific aims: (1) To characterize the overall patterns of e- cigarette use in adult e-cigarette users reporting interest in quitting vaping within the next 30 days, including e- cigarette quit attempts and putative antecedents of e-cigarette quit attempts (e.g., mood, craving, intent to quit, confidence in ability to quit) and (2) To examine the contextual and person-level factors that precede e-cigarette quit attempts and the period of time over which these factors provide the best prediction of near-term future quit attempts. Moderated growth curve analyses will allow us to examine the extent to which contextual and person-level factors predict future e-cigarette quit attempts and over what time periods. An immediate expected outcome of this proposal is refinement of the field’s knowledge of e-cigarette use patterns and short-term antecedents of discontinuation of e-cigarette use. The long-term outcome of this proposal is increased understanding of targets for intervention among e-cigarette users which will aid in the development of novel treatments for e-cigarette cessation. In 2018, almost 50 million adults reported use of any tobacco product, including e-cigarettes, which is responsible for over $300 billion in smoking related illness and the leading cause of preventable death in the United States. Knowledge gained from this proposal will refine the field’s understanding of e-cigarette use and cessation-related behavior and will help reduce tobacco-related morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Approximately 10.8 million adults in the United States report regular e-cigarette use (“vaping”) and many report plans to quit. There are currently no empirically supported interventions to help e-cigarette users quit vaping. By carefully examining patterns of e-cigarette use and attempts to quit vaping, we will uncover information that can be used to develop novel interventions to treat e-cigarette use in those wishing to quit vaping.